Regulation and impact of alternative splicing in biology and disease

Pre-mRNA splicing is a fundamental process required for the expression of most metazoan genes. Defects in
splicing lead to human genetic disease and splicing mutations in several genes involved in growth control have
been implicated in multiple types of cancer. Insights into the basic mechanisms of pre-mRNA splicing and
splice site recognition are therefore fundamental to understanding regulated gene expression and human
disease. The control of alternative splicing is a highly combinatorial process, where many inputs dictate the
splicing outcome for each exon. A critical feature of these regulatory mechanisms is the specific interaction of
trans-acting splicing factors with cis-acting RNA elements. We use a highly integrated approach to investigate
the molecular mechanisms that regulate pre-mRNA splicing. This includes knockout and knock-in tissue
culture models, reconstitution assays using radioligands, transcriptomics, bioinformatics, kinetics, structure-
function and biochemical techniques. In the next five years, we aim to address several outstanding challenges
in the field, pursuing the following novel research directions. (1) Our demonstration that splicing regulatory
proteins display highly position-dependent activities that negatively or positively influence splice site choice
changed the way we think about the classical splicing activators (SR proteins) and the classical splicing
repressors (hnRNPs). It is now appreciated that the context-dependent activation or repression of U1 snRNP
serves as a gateway to allow the abundant U1 snRNP to fulfill its splicing function and its role in protecting the
pre-mRNA from premature degradation. However, how splicing regulators achieve activation or repression of
U1snRNP at the 5’ splice site is not understood. We aim to dissect the mechanisms of splicing repression by
embracing multi-system approaches and by understanding the role of U1 snRNP conformers in mediating
spliceosomal assembly. (2) Intron retention is an important alternative splicing pathway that has eluded
extensive study. Thus, its regulation is not well understood. The existence of inefficiently spliced introns within
coding exons (exitrons) further highlights the biological importance of understanding when introns are removed
efficiently and when they are not. Using synthetic biology approaches, we will decipher the rules of efficient
intron removal and investigate the impact of cis-acting elements in this process. The argument is that the
depth of the sequence variation tested in massively parallel reporter assays is far greater than the testing
landscape that the human genome offers. Here, we will use our expertise in experimental molecular biology
and bioinformatics. (3) It has become widely appreciated that gene expression events are highly integrated,
with evidence suggesting that most pre-mRNA processing occurs co-transcriptionally. Defects in any one of
these steps have been linked to disease. However, most published studies evaluate only steady-state levels
of gene expression or focus only on a single step. This ignores the dynamics of gene expression steps that
collectively contribute to the generation of proteins from mRNAs. Thus, it is unclear how the kinetics of RNA
processing and mRNA stability translate into an endpoint gene expression signature. We have established a
reliable method to metabolically label nascent RNA, which allows us to track transcripts from synthesis to
degradation. Work in this project will probe how steady-state mRNA levels are established, how the splicing
and translation regulator SRSF1 influences mRNA dynamics, and how these processes adjust as a cell
undergoes transformation. The goals of our research program are to obtain a better understanding of exon
recognition and alternative splicing. The new mechanistic insights will be leveraged to improve strategies to
therapeutically target this essential gene expression step.

Public health relevance
Alternative pre-mRNA splicing is a crucial component of establishing appropriate gene expression programs that are unique to tissues and differentiated cell types. Defects in alternative splicing are known to associate with many human diseases. In this project we will analyze the mechanisms of regulated alternative splicing using a combination of experimental and computational approaches to provide detailed molecular insights into the control of gene expression and to identify novel disease targets.